Computational Studies of Molecular Medicine for Voltage-Gated Sodium Channels

Project Summary
A variety of mutations in voltage-gated sodium (Nav) channels are associated with a broad spectrum of
channelopathies, including epilepsy, autism, intellectual disability, migraines, pain syndromes, myopathies, and
cardiac arrhythmias. The genotype-phenotype relationship in Nav channels is profoundly complex, with identical
mutations sometimes leading to variable or even opposing effects. The molecular mechanisms underlying these
mutational disruptions remain largely unexplored, hindering structure-based drug design of targeted and
mutation-specific therapeutics essential for precision medicine. Moreover, the functional impacts of thousands
of Nav natural variants are still uncertain, challenging disease diagnosis and personalized treatment.
We hypothesize that the variable or opposing effects of a specific Nav channel variant, such as both
amplification (gain-of-function, or GoF) and diminution (loss-of-function, or LoF) of Na+ current, could arise from
its impacts on multiple functional transitions or diverse functional aspects. Alternatively, these variable effects
might be affected by the cross-talk between post-translational modifications (PTMs) and mutations. Given
mutations’ roles are intrinsically rooted in their structural dynamics during functional transitions or their dynamic
interactions with PTMs, molecular dynamics (MD) simulations are ideal to investigate the structural and dynamic
effects of these mutations. In this study, we employ customized MD and conformational free-energy calculation
strategies for several representative mutations to gain mechanistic insights within a practical simulation timescale.
A comprehensive investigation of thousands of uncertain variants via MD simulations or electrophysiology is
unfeasible due to resource and time constraints. While AI-based prediction offers a more efficient alternative,
current AI tools only provide binary prediction (benign/pathogenic or GoF/LoF). More precise phenotype
predictions are crucial for risk assessment, personalized treatment, and therapeutic innovation. We propose
developing a machine-learning model that integrates protein sequence, structure, dynamics, and function data
to accurately predict the gating properties of variants. This innovative approach could revolutionize the diagnosis
and treatment strategies of channelopathies.
This proposal outlines our ongoing efforts on three critical aspects of Nav channels using two computational
approaches: (i) MD simulations to investigate 1) how mutations affect structural transitions and channel gating
and 2) how mutation-PTM cross-talk leads to differential effects; and (ii) ML modeling to predict 3) the functional
impacts of new variants. As an Early-Stage Investigator (ESI) nearing the end of my eligibility period (until June
2025), this MIRA ESI proposal represents a critical juncture in my career. The timing of this application aligns
perfectly with my career goals and research trajectory. It provides a springboard for launching an innovative and
long-term computational program bridging the molecular pathophysiology of channelopathies and rational drug
design, promising lasting scientific impact in biophysics, pharmacology, and biomedical research of ion channels.
1

Public health relevance
Computational Studies of Molecular Medicine and Pharmacology of Voltage-Gated Sodium Channels Project Narrative A variety of mutations in voltage-gated sodium (Nav) channels are associated with diverse excitability disorders, yet their molecular-level impacts on channel function remain elusive. This project aims to elucidate the roles of mutations and their interactions with post-translational modifications in structural dynamics at the atomic level using molecular dynamics (MD) simulations. We also aim to develop a machine-learning model to predict variant effects of Nav channels, potentially revolutionizing diagnosis and treatment strategies of channelopathies. 1